Short-term biomedical research training program for veterinary students

Veterinary scientists are trained to be key contributors to One Health and are ideally situated to deliver services in biomedicine, zoonotic diseases, agricultural systems, ecosystems health, and spontaneous models of human disease. Exposure of DVM students to varied research programs is a critical first step in promoting their development in the scientific method. This training program is designed to build on the established and successful DVM Summer Research Program that has a >20-year record of recruiting and comprehensively immersing veterinary medical students in summer research experiences on the MSU campus. These research experiences focus on three major areas that align with the NIH mission: (1) Microbial ecology and evolution; microbial pathogenesis, microbial population structure and functioning in health and disease, Microbe-host- environment interface biology; (2) Comparative medicine (oncology, inflammation, cardiology, theriogenology, genetics, ophthalmology, orthopedics); and (3) Systems approach to population level investigations. The DVM summer research program at CVM includes a carefully planned delivery of modules required to prepare participating students for further training in the biomedical research. Our program is intentionally designed in both composition and content to provide an on-ramp for recruitment of the most qualified students into an immersive and comprehensive research experience. The primary objective of this T35 education research program is to increase the number of veterinary students with in-depth experience in hypothesis driven research who ultimately pursue biomedical research-related educational goals and career paths relevant to the core mission areas of the NIH. Toward this end, the program is designed to - 1) provide summer scholars a research experience and an overview of career opportunities in academia, government, and biomedical industry, 2) cultivate a science identity through mentor and peer networks, and 3) provide a positive reinforced framework to help foster confidence required to pursue a career in science.

Public health relevance
Narrative This proposal is to provide short-term, mentored research training to students at the beginning of their veterinary training and inspire them for careers in biomedical and translational research. Veterinarians are uniquely qualified to advance health of humans, animals, and the environment via their in-depth training and knowledge in 1) population systems, food safety, and security, 2) recognition and control of infectious diseases that are transmitted among animals and humans (interspecies), and 3) spontaneous animal models of human diseases. With the additional research training that will be acquired through this program, these future veterinary-scientists will be primed to pursue scientific interrogations to address the gaps in knowledge in the animal-human-ecosystem interface and various public health challenges facing the nation and make significant contributions throughout their careers.